Flexible Funding Model Maintenance for Washington State Manufactured Food Regulatory Program 2023-2026

Flexible Funding Model- Infrastructure Development and Maintenance for State
Manufactured Food Regulatory Programs (U2F) RFA-FD-23-027
Project Summary
The objective of this multi-component project is to support a nationally integrated human and animal
food (HAF) safety system through the maintenance of the Manufactured Food Regulatory Program
Standards (MFRPS) and the Washington Food Protection Task Force. The Washington State Department
of Agriculture (WSDA) plans to continue its conformance with current and future versions of the MFRPS
standards and Food Protection Task Force best practices in order to actively enhance standardized and
efficient HAF safety regulatory and response activities.
In addition to maintaining the core regulatory and response foundations that have been established
through MFRPS and RRT, WSDA plans to continue its efforts to identify and strengthen integral
professional relationships between HAF safety partners including Federal, state, local, and tribal
stakeholders in the public health, agriculture, regulatory, laboratory, industry, academic, and emergency
response arenas.
Through this multi-modal approach, WSDA anticipates the ability to contribute to an integrated
food/feed safety system in a standardized and efficient manner to better protect the public health of
Washingtonians and the U.S. population as a whole.

Public health relevance
Flexible Funding Model- Infrastructure Development and Maintenance for State Manufactured Food Regulatory Programs (U2F) RFA-FD-23-027 Project Narrative This project intends to improve the nationally integrated human and animal food safety system through maintenance of the manufactured food regulatory program standards, food/feed Rapid Response Team, and Food Protection Task Force in Washington State. Through continued innovation, standardization, and collaboration between stakeholders both internal and external to the agency, the Washington State Department of Agriculture intends to work toward continually improved food safety and thus improved public health protection both within Washington State and nationally.